ENRICHMENT PROGRAM

The UCSD/UCLA/Salk/Cedars-Sinai Diabetes Research Center Enrichment Program serves as the focus of interaction within and between the four institutions, organizing meetings, seminar series, and retreats to facilitate communication, learning, training, and collaboration. It plays a vital role in advancing diabetes research, catalyzing interdisciplinary, inter-institutional research programs, disseminating new research findings, fostering junior scientists, and increasing awareness of the importance of diabetes research. Directed by Dr. Maike Sander (UCSD) and Dr. Mark Goodarzi (Cedars-Sinai), this enrichment program is vital, exciting and multidisciplinary, reaching broadly across pediatric and adult diabetes, Los Angeles and San Diego, and inviting seminar and retreat speakers nationwide relevant to all five research bases, and coordinating with the P&F program to feature our junior faculty and foster training of junior faculty, clinical fellows, postdoctoral fellows, medical students, and graduate students, drawing the next generation of outstanding scientists into diabetes research. The Enrichment Program has four goals: 1). Advance communication,.integration, and interaction between the investigators in diabetes research within the four affiliated institutions. 2). Organize annual retreats including DRC Day Retreats, the P&F Symposium and our DRC Seminar Series in Los Angeles and La Jolla. 3). Promote the careers of investigators in diabetes and metabolic diseases, and 4). Promote collaborative interactions among DRC investigators. This highly successful effort is crucial to the UCSD/UCLA DRC and the scientific community it serves.

Public health relevance
The Enrichment Program of the DRC is essential to our mission of advancing diabetes research. It is particularly important for a Diabetes Center such as ours that brings together researchers from four institutions across Southern California and reaching our five research bases in type I and type II diabetes research.